KSHV Infection And Persistence

Kaposi's sarcoma (KS) herpesvirus (KSHV) is the etiologic agent of KS and primary effusion lymphoma
(PEL), and is tightly linked with multicentric Castleman's disease (MCD). These tumors are most common in
immune suppressed individuals, especially those with AIDS. There are no specific therapies for KSHV
malignancies. KS is a leading AIDS malignancy, and is epidemic in sub-Saharan Africa. KS often involves the
oral cavity and can disseminate to visceral organs. Saliva is the KSHV vehicle of transmission.
For unknown reasons, and in contrast to other herpesviruses, which are ubiquitous, KSHV
epidemiology mirrors that of P. falciparum malaria and certain helminth infections. Accordingly, seroprevalence
is high in sub-Saharan Africa (~80%) and much lower in western nations (~5%) that lack similar endemic
infections. KSHV seroprevalence is also elevated (30-60%) in men who have sex with men.
Latency is the hallmark of KSHV and gammaherpesvirus infection during which only several of its ~100
genes are expressed. KSHV latently infects cells, including tumor cells, and viral genomes persist as
extrachromosomal, circularized, multi-copy, episomes.
KSHV establishes lifelong infection, and persists in latently infected B cells. Paradoxically, however, in
vitro infection of B cells is inefficient, and cells are short lived, suggesting absence of necessary factor(s).
MCD infected cells exhibit B cell plasmablast characteristics, and PEL cells those of plasma cells,
suggesting these diseases derive from aberrant development at different stages of B cell infection. B cells may
differentiate to plasmablasts and long-lived plasma cells by proceeding through a germinal center reaction, in
which they undergo somatic hypermutation, thus producing high affinity antibody. Alternatively, B cells may
progress through an extra-follicular pathway to generate plasma cells. In this case, somatic hypermutation is
typically absent, with low affinity antibody produced. MCD and KSHV (alone, without coinfecting EBV) PEL
cells lack somatic hypermutation suggesting development from an extra-follicular pathway.
We recently found KSHV infects mononuclear phagocytes (monocytes, macrophages) with high
efficiency, and that these cells drive latently infected B cell differentiation to plasmablasts and then long lived
plasma cells, thereby promoting long term KSHV B cell latency. Monocytes are elevated in malaria and in the
helminth infections KSHV is associated with, suggesting increased phagocyte abundance in those parasitic
diseases may underlie KSHV’s geographic disparity.
These findings therefore demonstrate a key role for mononuclear phagocytes in B cell latency,
providing a new paradigm for KSHV B cell latency establishment. Here, we use rigorous, detailed, in depth
approaches to investigate the interactions occurring between KSHV, mononuclear phagocytes, and B cells that
lead to long term KSHV B cell latency.

Public health relevance
Project Narrative Kaposi’s sarcoma-associated herpesvirus (KSHV) has an etiologic role in several human cancers. KSHV establishes long-term infection in cells and persists in these cells in a latent state. This work seeks to understand the mechanisms this virus uses to allow it to be maintained in cells since a better understanding may allow development of strategies which prevent KSHV cancers.